MOLECULAR AND STRUCTURAL BASES OF HYPOTHALAMIC PUBERTY

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. This is a subcontract aimed at understanding the physiological mechanisms responsible for the onset of puberty in humans. Studies performed in Dr. Ojeda's lab are those proposed under Specific Aim 3 of the main application, which is: "To determine, in the absence of interfering testicular hormone feedback, the global profile of hypothalamic gene expression at the time of 1) the suppression of pulsatile GnRH release during infancy, and 2) the resurgence in pulsatile GnRH release at the end of the juvenile phase of development". The rhesus monkey is being used as an experimental paradigm.